Administrative and biostatistics core

DESCRIPTION Core A is comprised of two components that provide two important support services for the Program Project. The first service is the Administration Sub-Core (A1) that will provide administrative and financial oversight, communication, coordination among the four Projects and Core B. This will include providing secretarial support to the PI, Project Leaders and Core Directors. The Administrative component also coordinates overall program oversight by the Internal and External Advisory Boards. It will provide a centralized structure for the coordination of the research meetings, travel arrangements, and annual retreats. It will also provide overall support for the preparation of the annual research progress reports and facilitate communication with the Internal and External Advisory Boards. The second service is the Biostatistics Sub-Core (A2). This component provides direct biostatistics support and Program Data and Resource Management for the four Projects and Core B.

Public health relevance
PROJECT NARRATIVE The three RAS genes comprise the most frequently mutated gene family in cancer, with highest frequencies seen in three of the top four causes of cancer deaths in the US. This Program Project aims to better understand the complexities of RAS oncoproteins to guide efforts to develop anti-RAS drugs for cancer treatment. Anti-RAS drugs are expected to make a significant impact on cancer deaths in the US.